A randomized controlled trial to support smoke-free policy compliance in public housing

Project Summary
Tobacco use remains a leading cause of preventable premature death in the United States, especially for
racial/ethnic minorities and low-income populations. Public and multiunit housing are closely tied to tobacco-
related disparities as vulnerable populations are most likely to live in multiunit housing with the highest rates of
smoking and secondhand smoke exposure, while also the least likely to have access to smoke-free home
environments. For example, New York City Housing Authority (NYCHA) residents smoke at higher rates, report
higher secondhand smoke exposure from an outside source and are surrounded by high density tobacco retail
environments compared to other New Yorkers. Public housing is at the forefront of the smoke-free policy
movement. In 2016, HUD mandated that all housing authorities adopt smoke-free policies, which affects all
3,300 housing authorities and 1.2 million households nationwide. NYCHA is the largest public housing provider
in the nation; it houses more than 400,000 people in 326 public housing developments spanning over 2,400
buildings citywide. As of July 2018, all NYCHA housing units adopted a smoke-free policy affecting all
properties. The implementation of this policy, the largest of its kind, represents a critical opportunity to examine
and reduce public housing-related tobacco hazards. To date, no randomized controlled trials (RCT) have been
conducted to test the effects of compliance strategies on resident smoking behavior and secondhand smoke
exposure. The proposed design will be a borough-stratified, four-arm, factorial-design, cluster RCT that will
target 128 randomly selected buildings (32 buildings per arm) in separate NYCHA developments. We will
recruit and follow 8 randomly selected residents stratified by smoking status- 4 smokers and 4 non-smokers-
per building (n=1024) into four arms: (1) relocation/cessation, (2) resident endorsement, (3) relocation/
cessation plus resident endorsement and (4)the standard approach (256 participants per arm). Outcomes
will be assessed longitudinally using salivary cotinine and resident surveys to measure smoking behaviors and
secondhand smoke exposures at 4 time points: baseline, 2, 6 and 12 months post-intervention. Qualitative
data will also be collected via key informant interviews, focus groups and sensory observations of buildings.
This mixed methods, pre-post with comparison RCT design overseen by a highly experienced, interdisciplinary
team in partnership with NYCHA and a stakeholder advisory board. Aims include to experimentally test if policy
compliance interventions reduce personal smoking behavior (Aim 1); reduce secondhand smoke exposure
(Aim 2), and determine if the tobacco retail environment surrounding each building moderates the relationship
between compliance interventions and smoking-related outcomes (Aim 3). This comprehensive, community
engaged and social-ecologically informed RCT supports the design and implementation of interventions to
optimize smoke-free housing compliance for populations with high burdens of tobacco-related disparities.

Public health relevance
Project Narrative Smoke-free housing policies in multiunit housing are promising and increasingly widespread interventions to reduce smoking and secondhand smoke exposure. Little research has identified factors that impede compliance with smoke-free housing policies in low-income multiunit housing and test corresponding solutions. The proposed RCT addresses key gaps in knowledge and capitalizes on key scientific opportunities by: 1) leveraging the federal mandate to ban smoking in a public housing system of more than sufficient size to conduct an adequately powered RCT; 2) expanding our understanding of smoke-free policy compliance beyond policy implementation by testing two novel treatments: a) in-residence smoking cessation and b) resident endorsement, while 3) addressing population and location-specific tobacco-related disparities.